Advancing Proteomics Technologies for Cancer Research

Project Summary
I am the Technical Director of the Proteomics and Macromolecular Crystallography Shared Resource (PMCSR)
at the Herbert Irving Comprehensive Cancer Center (HICCC), Columbia University Irving Medical Center
(CUIMC). I joined PMCSR in 2018 and established and expanded the service portfolio. Utilizing cutting-edge
mass spectrometers and innovative methodologies, PMCSR has been supporting various research programs,
including Cancer Genomics and Epigenomics, Precision Oncology and Systems Biology, Cancer Population
Science, and Tumor Biology and Microenvironment. Its impact is evident in the novel immunotherapy targets
identified, the deeper understanding of cancer pathogenesis achieved, and the elucidation of key mechanisms
driving tumorigenesis. The PMCSR's services have been widely utilized not only within HICCC and Columbia
University but also by external cancer centers, highlighting its significance in the broader research community.
This widespread usage underscores the PMCSR's exceptional reputation, evident in its outstanding rating during
the recent P30 Comprehensive Cancer Center grant renewal. In the past five years, I have been a co-author of
47 peer-reviewed articles. My aim is to enhance PMCSR's capabilities further by advancing existing technologies
and introducing innovative methodologies, including Automated Deep Proteomic Profiling for Biofluids,
Comprehensive Pipeline for Immunopeptidomics and Cell Surfaceome Profiling, and Lab Automation. The
successful implementation of these technological advancements will significantly impact cancer studies,
attracting substantial funding, fostering collaborations, and leading to high-impact publications. In summary, this
award will provide career stability to me and allow me to continue excellence in serving the cancer research
community. The advancements will not only elevate the PMCSR's capabilities but also enrich the broader
landscape of cancer research, marking a significant impact toward improved diagnostics, treatments, and
ultimately, a cure.

Public health relevance
PMCSR serves as the backbone for diverse research initiatives, highlighted by the utilization of over 200 laboratories engaged in basic, clinical, and translational research. PMCSR's cutting-edge technologies have been pivotal in numerous groundbreaking studies, including interactome mapping elucidating crucial mechanisms in cancer immunity, phosphoproteomics uncovering dysregulation leading to lymphomagenesis, and cell surfaceome profiling aiding immunotherapy target discovery. This award will provide career stability to me and allow me to continue excellence in serving the cancer research community.